BID Core with P1 and P2

PROJECT ABSTRACT
Core B – Behavioral Intervention Development Core
The goal of the Behavioral Intervention Development Core of the Northwell Roybal Center for
Personalized Trials: Physical Activity Promotion for Persons Giving Care or Living with AD/ADRD is to
obtain the needed behavioral intervention development information and adequately powered trial results that
can be translated into scalable, implementable interventions through innovative mechanisms of behavioral
change (MoBC), behavior change theories and techniques, and innovative, personalized N-of-1 methods,
where the latter are found to be effective and useful.
The Behavioral Intervention Development (BID) Core will proactively determine a national pool of potential
eligible scientists for later national competitions, review and select meritorious clinical trials for funding; and
ensure compliance of all clinical trials with all regulatory agencies. The BID core will then support investigators
identified via this national competition to implement identified innovative clinical trials which align with the
themes of the Northwell Roybal Center in Years 3 through 5 of the proposed project. The BID Core will also
support the conduct of two Stage II fully-powered clinical trials in Years 1 and 2 which aim to foster habitual
physical among caregivers for persons with AD/ADRD. Trial #1 will work to develop habitual daily walking
among caregivers while Trial #2 will work to develop habitual hourly walking as a means of reducing the
amount of time caregivers spend sedentary. Both trials will measure the key mechanism of behavior (MoBC) of
cognitive automaticity.
The overall mission of the Northwell Roybal Center for Personalized Trials is to establish an infrastructure
organized per the NIH Stage Model with scientiﬁc expertise and resources to conduct Stages 0-V trials of the
translational behavioral intervention development pipeline, as well as examining key MoBCs Stages 0-V trials
of behavior change, and so serve as a national resource for the behavioral and social intervention research
community in initiating and maintaining personalized physical activity regimen for caregivers or persons living
with AD/ADRD.

Public health relevance
See attachment in Overall Component, Other Project Information, Narrative